The Roles of Lipid Metabolism in the Maintenance of Hematopoietic Stem Cells

PROJECT SUMMARY
While early findings suggested that hematopoietic stem cells (HSCs) depend mainly on glycolysis, emerging
evidence from our lab and others has shown that mitochondrial metabolism, and particularly fatty acid oxidation,
is essential to HSC fate determination. We hypothesize that mitochondrial metabolism is remodeled at the
initiation of the fate choice process to meet the changing needs of proper HSC function. However, our
understanding of the relationship between HSC self-renewal and lipid metabolism remains limited. A leading
goal of our research is identification of the key metabolic pathways directing hematopoietic stem cell (HSC) fate
decisions. The goals of our ongoing study are three-fold: (1) In Aim 1, we will induce the selective consumption
of metabolites localized in the mitochondria to identify metabolic targets of fatty acid metabolism that affect HSC
fate; (2) in Aim 2, we will use pharmacological or genetic modulation of key genes impacting fatty acid oxidation
or its downstream targets to define the metabolic crosstalk between mitochondria and the cytosol; and (3) in Aim
3 we will evaluate the coordinated process that yields HSC division symmetry in vivo, and analysis of division
balance will provide insights into the in vivo relevance of fatty acid metabolisms to HSC fate choice. If successful,
our research will positively impact the field by providing a deeper understanding of the metabolic cues
coordinating HSC fate decisions, and will suggest potential methods of shifting the division balance of HSCs
toward self-renewal through metabolic manipulation to improve clinical outcomes after transplantation.
In this diversity supplement, we propose to include Mr. Carlos Hurtado Muñoz as a primary member in our R01
project, which focuses on studying the roles of lipid metabolism in the maintenance of HSCs. Carlos is a young
scientist with an impressive research background despite his age, highlighting his dedication to translational
research. Throughout his undergraduate career, he devoted every summer to full-time research at various
academic institutions, equipping him with the essential understanding and technical skills required to excel in
our project. We will develop Mr. Hurtado Muñoz’ participation in this project as part of a structured training
experience. We describe in this proposal how his project activities will involve activities that are designed to
foster transferrable skills. These skills will not only be related to the field of hematology/stem cell biology but also
project management, communication, leadership, and supervisory skills, and training in ethics and integrity. Mr.
Hurtado Muñoz has defined his career goal explicitly as a future independent physician-scientist. Our goal during
the R01 project is to give him the skills and publications that will offer the foundation to make Mr. Hurtado Muñoz
an ideal candidate for the top MSTP programs in the United States. Throughout his continued involvement, he
will benefit from co-mentorship by Dr. Claudia Morganti, PhD, and the principal investigator, Dr. Keisuke Ito, both
of whom will provide unwavering support to Carlos at every stage of the process. We are thrilled and deeply
appreciative of the chance to nurture and train a Colombian-American student who aspires to become an
independent physician-scientist in the field of hematology and stem cell biology.

Public health relevance
PROJECT NARRATIVE In this project supplement, a Colombian-American student centrally into our R01-funded project to study the key metabolic pathways directing hematopoietic stem cell (HSC) fate decisions. Mr. Carlos Hurtado Muñoz will be trained to perform all of the molecular, metabolomics and genetic assays and the data analyses in the Ito lab. Our goal is to provide the training experience that will build a skill set that Mr. Hurtado Muñoz will use a foundation for his career as an independent physician-scientist.